Graduate Program in Bioethics in Research

PROYECT SUMMARY
Project: Graduate Program in Bioethics in Research
PD/PI Names: Montoya, Juny and Fernández Pinto, Manuela
Organization: University of los Andes
Project Period: 07/05/2022 - 06/30/2027
The master’s program in Bioethics in Research aims to develop knowledge and skills for
understanding and analyzing the ethical aspects of health sciences, biomedical sciences, and
health management, contributing to the individual and collective resolution of relevant ethical
problems, and to the training of educators on these matters.
Recognizing the existing needs in Latin America for professionals with multidisciplinary
knowledge in bioethics in research, this master's program will emphasize the development of
pedagogical competences that allow our graduates to become trainers and solve ethical
problems that frequently emerge from conflicts between the socioeconomic conditions of the
region and the priority of improving public health.
To this end, the master’s program focuses on the development of the necessary skills for
ethical management of health care, research, as well as public health management ensuring the
protection of fundamental rights for all research participants. At the same time, students will
develop skills to guide, carry out, and communicate bioethical research from a multidisciplinary
perspective.
Our graduates will be prepared to work in health institutions, universities, pharmaceutical
laboratories, research centers, IRBs, government agencies, and other related institutions, in
which ethical health challenges must be addressed, always aiming for the integral well-being of
citizens. We aim for our graduates to become multipliers of bioethics in research expertise,
which is nowadays in high demand in the region, as many Latin American countries move
towards the creation, implementation, and regulation of IRBs. Our goal is to make a significant
contribution in these endeavors.
The overall duration of the program is two years, based on a part time dedication
ranging from 16 to 24 hours per week, according to the total of credits registered for each
academic term.
The
master
’s
degree will admit 20-30 students per year.

Public health relevance
PROYECT NARRATIVE Project: Graduate Program in Bioethics in Research PD/PI Names: Montoya, Juny and Fernández Pinto, Manuela Organization: University of los Andes Project Period: 07/05/2022 - 06/30/2027 The master’s program in Bioethics in Research from University of Los Andes will be offered jointly by the Center of Applied Ethics, the School of Medicine, and the School of Economics, offering a unique interdisciplinary approach to the study of bioethics, with an emphasis on research ethics and the health sciences. As an online program, the master’s program will fill the shortage of quality education in Bioethics and Research Ethics not only in Colombia, but in other Latin American countries. With an innovative design driven by active, practice-oriented, and problem-based learning, the program will ensure that participants develop the necessary skills and competencies to approach ethical challenges in health research today.